Early Life Stress, Chronic Drug Use and Neuroplasticity in Nonhuman Primate Models of Cocaine Abuse: Relevance to Treatment Strategies

Abstract
Despite the risks of adolescent initiation of drug use for lifelong addiction and its tremendous health and
societal costs, the neurobiological factors leading to increased vulnerability to substance use disorders (SUDs),
including cocaine (COC) use disorder (CUD), are poorly understood. Early life stress (ELS), including adverse
experiences such as childhood maltreatment (MALT), is a major risk factor for psychopathologies like SUDs,
anxiety and depression, which are often comorbid. Indeed, individuals with histories of childhood MALT are
more vulnerable to COC addiction, and deficits in emotional regulation predisposes them to stress-induced
relapse, contributing to spiraling of drug taking. Despite these risks, how ELS and COC abuse during
adolescence interact to alter brain development, increasing vulnerability to CUD later in life, has not been
elucidated. There are also strong sex differences in progression from initiation of drug use during adolescence
(experimentation) to the onset of drug dependence, with women showing increased vulnerability, although the
underlying neurobiological mechanisms are unclear. The goal of this proposal is to examine long-term ELS-
related impact and neurobiological mechanisms of increased risk to CUD during adulthood. To accomplish this,
we are using a unique and highly translational nonhuman primate (NHP) model of infant MALT with
adolescence COC self-administration (SA) and addressing sex differences. The studies proposed here with a
cohort of adult macaques that experienced infant MALT followed by COC SA during adolescence, and
characterized longitudinally since birth, are unparalleled. They will provide information of critical relevance for
the human HEALthy Brain and Child Development (HBCD) and Adolescent Brain Cognitive Development
(ABCD) NIH studies by examining early risk factors and neurobiological mechanisms for SUDs.
The studies leverage this unique cohort of animals during adulthood to examine the long-term impact of ELS
and adolescence COC SA on neurobiology of reward and stress/emotion regulatory circuits following a year of
COC abstinence (Aim 1), neurobiological changes in dopamine (DA) and serotonin (5-HT) receptors and
functional connectivity (FC) of prefrontal cortex (PFC) with ventral striatum (nucleus accumbens) and
amygdala following re-exposure to COC SA (Aim 2), and the rate of recovery of DA and 5-HT receptors and
FC during abstinence from long-term COC, to investigate whether it predicts COC-induced relapse and
responses to pharmacological interventions targeting DA and 5-HT receptors; PET data will inform
personalized medicine approaches (Aim 3). We hypothesize differential effectiveness of DA and 5-HT receptor
compounds (alone vs. mixtures) in MALT than Control animals, and in females versus males. We propose that
ELS, in addition to adolescence COC exposure, leads to the dysregulation of reward and stress/emotional
systems typically reported in human psychiatric conditions, resulting in increased risk to CUD in adulthood, in
comparison to animals with COC adolescence exposure but no ELS history.

Public health relevance
Project Narrative Early life stress (ELS) is a major risk factor for cocaine (COC) use disorder (CUD), but it is unclear how ELS and COC abuse during adolescence interact to alter brain development to increase vulnerability to CUD during adulthood. The goal of this proposal is to examine long-term impact of ELS on neurobiological systems that increase risk to CUD during adulthood, using a unique and highly translational nonhuman primate (NHP) model of ELS (infant maltreatment) with adolescence COC self-administration and addressing sex differences. These prospective, longitudinal studies in NHPs are critical to identify the neurobiological mechanisms of risk of CUDs and lifelong addiction, including relapse following abstinence, and to develop pharmacological interventions that target dopamine and serotonin receptors specifically for at-risk populations.